Alternative NF-kB activation in post-chemotherapy setting to elucidate novel mechanisms of ovarian cancer relapse

Scientific Abstract
Ovarian cancer is the most lethal gynecological malignancy in the United States and although patients initially
respond to cytotoxic chemotherapy, most relapse with chemoresistant disease within 24 months. There are
several critical gaps in our knowledge of the mechanisms that support disease recurrence but research over the
last decade support the notion tumor-initiating cells (TICs), a subpopulation of drug resistant tumor cells, are
responsible for facilitating relapse and combination therapies targeting these elusive cells may lead to longer
remission or even cures. Although numerous genes and signaling pathways have been implicated in maintaining
TICs, there are several critical gaps in our understanding of the processes these cells use to survive cytotoxic
chemotherapy and successfully re-establish tumors. For example, it is unclear whether pathways active in TICs
are constitutive or if they can be induced by factors in the tumor microenvironment (TME). Our previous studies
revealed an important role for alternative NF-kB signaling in maintaining ovarian TICs and resistance to cytotoxic
chemotherapy. NF-kB is a family of transcription factors that respond to signals in the TME to promote
proliferation, chemoresistance, and survival of cancer cells. Emerging evidence suggest alterations of the TME
following cytotoxic chemotherapy can result in the release of signaling factors that can activate NF-kB in cancer
cells. Our recent data show that TWEAK, a multifunctional cytokine secreted from macrophages and stromal
cells, is elevated in the TME following chemotherapy and can induce activation of alternative NF-kB and
expression of stemness genes in a variety of ovarian cancer cells. Clinical data from patients undergoing
neoadjuvant chemotherapy show that genes encoding TWEAK and alternative NF-kB family members are
significantly elevated in tumors resected following cytotoxic chemotherapy relative to pre-treatment levels. These
data lead us to our central hypothesis that chemotherapy provides an environment that favors TIC development
through activation of alternative NF-kB. To investigate this hypothesis, we will 1) determine whether
chemotherapy-induced TWEAK signaling in the ovarian TME activates alternative NF-kB in ovarian cancer cells
2) establish the function of the alternative NF-kB kinase, NIK, in ovarian cancer chemoresistance and relapse
and 3) investigate the role of NF-kB-mediated activation of Notch in supporting ovarian TICs following
chemotherapy. Unlike most published studies, we are focusing on the pathways and activities in these cells after
chemotherapy, to generate new paradigms for evaluating relapse mechanisms. Given the strong initial response
to chemotherapy, it is of great interest to identify an early post-treatment event that could be targeted in
combination with cytotoxic drugs to inhibit pathways that maintain TICs. Clarifying novel mechanism(s) by which
this under-examined pathway supports chemoresistance will guide the design of better therapies to prolong
remission or potentially achieve cures for ovarian cancer patients.

Public health relevance
Narrative Ovarian cancer is usually diagnosed at a late stage when survival is only about 10%, rendering this disease the deadliest gynecological malignancy. Disease recurrence is the major cause of mortality and despite a greater understanding of ovarian cancer biology there have been no significant improvements in mortality rates in the last five decades. Investigation of tumor cells that are resistant to chemotherapy and have the capacity to regenerate tumors is crucial for achieving cures for ovarian cancer patients.